Hypoxic incubator for physiological cell culture research

SUMMARY
This proposal requests funds to acquire a hypoxic incubator and workstation in one, which provides precise
control of temperature, humidity, oxygen and carbon dioxide levels. Oxygen levels can be controlled in 0.1%
increments from 0.1% to 20%, thus encompassing the various levels found in tissues, including in tumors which
often are extremely hypoxic with levels ranging between 0.3 and 2.0% oxygen. This application will directly
support 6 NIH-funded investigators and 3 young investigators currently applying for NIH funding. Each of these
investigators has specific projects that benefits from the unique aspects of the HypOxystation® H35 workstation.
Cells that are under low oxygen tension accumulate and activate hypoxia-inducible transcription factor alpha-
subunits HIF-1a and HIF-2a, leading to pleiotropic effects including modulating cellular metabolism, cell cycle
and anti-inflammatory activities. Availability of this instrument will enable crucial investigations of the role of
hypoxia in modulating the immunogenic effects of radiation, antigen presentation in cancer and diabetes, and
mitochondrial dysfunction in autoimmunity. Unique features of the HypOxystation® H35, including a large
workspace, sample input/output port, sleeve ports and precise environmental control and monitoring produce
stable atmospheric conditions for culturing and manipulating samples, which is required for carrying out rigorous
research into the role of oxygen tension within a biological system. The HypOxystation® H35 will provide
capabilities to Weill Cornell Medicine and neighboring institutions and will be supervised by an advisory
committee, overseen by the Radiation Oncology department, and will thus positively impact basic and
translational NIH-funded research. The NIH-funded research programs supported by this instrumentation have
relevance to cancer biology and treatment, immunology, metabolism, and autoimmunity.

Public health relevance
NARRATIVE One of the most important requirements for biomedical research is to use models that are relevant to patients. In this application, we propose acquiring a state-of-the-art instrument that provides unprecedented ability to perform in vitro experiments using oxygen levels that mimic the different levels present in tissues in different physiological and pathological conditions, including cancer, inflammation and diabetes. This instrument will enhance the scientific rigor and translational relevance of the research performed by several of NIH-funded research projects at Weill Cornell Medicine.